Development of oral KCC2 enhancer drug for treatment of painful diabetic neuropathy

Development of oral KCC2 enhancer drug for treatment of painful diabetic neuropathy.
Abstract:
There is a need for more effective drug treatments for diabetic neuropathic pain (DNP), which affects one-third
of people with diabetes. Current analgesics have unpredictable efficacy and debilitating side effects that can
outweigh pain relief. Despite its impact on quality of life, there are no disease-modifying treatments for DNP.
In recent years, growing evidence shows that neuropathic pain in diabetic neuropathy and other
disorders is caused by spinal disinhibition secondary to hypofunction of KCC2, a CNS-specific chloride
transporter that is essential for neuronal responses to inhibitory neurotransmission. KCC2-enhancing
treatments are effective in animal models of neuropathic pain, including diabetic rats, with analgesic effects in
both males and females. Therefore, treatments that restore KCC2 function and neuronal chloride homeostasis
within dorsal spinal cord could directly address central pathological mechanisms of DNP, therapy alleviating
neuropathic pain and improving quality of life of DNP patients. AXONIS Therapeutics is advancing a first-in-
class oral KCC2 enhancer drug, AXN-006-01-3, towards clinic with GLP-toxicology studies planned for Q4
2022. In this Phase 1 SBIR application, we aim to complete key proof of concept studies to show that AXN-
006-01-3 can treat neuropathic pain in a DNP model. Additionally, impaired HRDD is a biomarker of spinal
disinhibition, and correlates with drug analgesic efficacy, in both DNP models and patients. Because HRDD
impairments reflect KCC2 hypofunction and respond to KCC2 treatments, we will examine HRDD as a
translational, electrophysiological biomarker of our KCC2-enhancing small molecule drug for DNP. Finally, we
will investigate PK/PD relationships using a confocal-based neuronal KCC2 biomarker.

Public health relevance
Project Narrative: One-third of diabetic patients will suffer from painful diabetic neuropathy, and current treatments have unpredictable efficacy and debilitating side effects that can outweigh pain relief. Hypersensitivity to pain in diabetic neuropathy involves the disinhibition of pain signals within the spinal cord. We are developing an orally administered drug that acts to rebalance the neuron activity within the spinal cord, without sedative side effects, in order to alleviate neuropathic pain and improve quality of life of DNP patients.